Persistent Effects of Dietary Protein Restriction on Protein Motivation and Underlying Physiology

Project Summary
It is often assumed that animals rapidly adapt behaviorally and physiologically to nutritional challenges and that
adaptations to such challenges carry implications for human health. Very little work has been conducted to
directly test this assumption and our preliminary data indicate that dietary protein restriction exerts effects on
protein motivation that continue once protein intake is normalized. The proposed project will assess the
persistence of the effects of dietary protein restriction on two measures of protein motivation – preference and
economic “demand” – and on the physiological correlates of protein motivation – FGF21 production and
mesolimbic dopamine system activity in response to protein ingestion. The work proposed in this application
will be the first to address the question of how animals adapt behaviorally and physiologically when dietary
protein is normalized following a period of dietary protein restriction. This work will be significant because it will
directly test the assumption, implicit in most work in the field, that animals dynamically respond to nutritional
needs.

Public health relevance
Narrative The current project will determine whether dietary protein restriction exerts persistent effects on protein motivation and its physiological correlates following normalization of protein intake.